Development of a web-based predictive model of nanoparticle delivery to tumors by integrating physiologically-based pharmacokinetic modeling with artificial intelligence

Project Summary and Abstract
In the field of nanomedicine, there are several challenges: (1) the delivery efficiency of nanoparticles (NPs) to
tumor is very low (<1% injected dose); (2) it is unknown whether there is a sex difference in tumor delivery
efficiency of NPs; (3) there is a lack of models that can predict distribution of NPs and the carried drug to tumor
and major organs and extrapolate from animals to humans. To address these challenges, the objective of this
renewal application is to develop a mechanistic, well-validated, and predictive generic physiologically based
pharmacokinetic (PBPK) models for NPs and the carried drug in male and female tumor-bearing mice that is
extrapolatable to rats. We hypothesize that tissue distribution and tumor delivery of NPs and the carried drug
can be predicted with a well-trained PBPK model by using species-specific, sex-specific, and NP-specific
parameters with machine learning and artificial intelligence (AI) approaches. Compared to the previous cycle of
this R01 grant, this renewal is innovative in several aspects: (1) the first time to systemically analyze whether
there is a sex difference in tumor delivery efficiency of NPs; (2) the first PBPK model for NPs in tumor-bearing
animals to evaluate the cross-species extrapolation capability, which is critical to extrapolate animal results to
humans; (3) the previous cycle of this grant only focused on NPs in tumor using a single-task learning model,
but this renewal will comprehensively analyze distribution of NPs and the carried drug to both tumor and major
organs using multi-task learning models. Three specific aims were designed. Aim 1: To develop a PBPK model
for NPs and its carried drug in male and female tumor-bearing mice using traditional PBPK approaches. Aim 2:
To develop a robust, validated and predictive AI-assisted generic PBPK model for NPs and its carried drug in
male and female tumor-bearing mice by employing machine learning and AI approaches. Aim 3: To validate
our PBPK model with new experimental data, extrapolate it to rats, and convert it to an AI-empowered web
dashboard. In Aim 1, we will create a Nano-Drug Database by including new data published from 2021-2029,
especially new data on the carried drugs of NPs, which were not included in previous studies. In Aim 2, the
multi-task machine learning model enables to determine the impact of distribution to major organs on tumor
delivery efficiency. In Aim 3, we will conduct original pharmacokinetic and tissue distribution experiments in
both tumor-bearing mice and rats to evaluate and validate our model. This project is significant because it
directly addresses the low tumor delivery efficiency of NPs, which is a critical barrier to progress in this field
for >2 decades. This project has broad impacts because this project will create tangible nanomedicine
database and AI-empowered PBPK model to answer a key question on the potential sex difference, improve
our scientific knowledge on key determinants of tumor delivery efficiency of NPs, and provide a high-
throughput screening tool to improve our technical ability to efficiently screen and design new nanomedicines,
and help reduce animal experimentation and ultimately accelerate clinical translation of nanomedicines.

Public health relevance
Project Narrative Many laboratory studies have demonstrated that nanoparticle-based drug formulations (i.e., nanomedicines) are effective in diagnostics and therapeutics of cancer in mice, but the translation of animal study findings to clinical success in humans is limited, partially, because of a low delivery efficiency of nanoparticles to the tumor and a lack of a robust computer model that can predict the tumor delivery efficiency of nanoparticles and the carried drug and extrapolate the results from animals to humans. This project is relevant to public health because the knowledge, data, and computer models gained from the proposed research will answer a key question of whether there is a sex difference in tumor delivery of nanoparticles and will also improve our understanding of the key determinants of tissue distribution and tumor delivery of nanoparticles and the carried drug, which are essential for the design of effective nanomedicines. In addition, the proposed research will create a publicly available web dashboard that enables researchers to predict delivery efficiency of nanoparticles and the carried drug to tumor and major organs in one animal species and then extrapolate to another animal species, which will greatly help to reduce animal experimentation in nanomedicine studies and accelerate clinical translation of nanoparticle-based anticancer drug formulations to benefit cancer patients.